Feasibility of an ADAPTive intervention to improve food security and Maternal-Child Health

Project Summary/Abstract
The US is facing a maternal and infant health crisis with stark disparities according to race, ethnicity, and
socioeconomic status. Food insecurity (FI) affects 30% of pregnancies and is a significant contributor to these
health disparities. FI leads to worse health in pregnant people and their children, including an increased risk of
gestational diabetes, pre-term birth, and future cardiometabolic chronic conditions. Interventions used to
address FI in clinical care settings include 1) referring patients to the Special Supplemental Nutrition Program
for Women, Infants and Children (WIC) or providing food via 2) produce vouchers and 3) medically-tailored
meals. Although there is evidence for each, patients differ in the support they need to reduce FI. Rather than
using a single FI intervention, adaptively allocating interventions could be a more effective, equitable, and
efficient approach to improve food security for the large, vulnerable population of pregnant patients with FI.
Our long-term goal is to develop an effective adaptive intervention that health systems can use to address FI
and improve metabolic health in pregnant patients and their offspring. The objectives of this pilot study are to
determine 1) the feasibility of recruitment and retention and 2) the potential effectiveness of the interventions in
anticipation of a large, definitive Sequential Multiple Assignment Randomized Trial (SMART). SMART uses
experimental design principles to build optimal adaptive interventions. In this pilot study, pregnant patients with
FI will be randomized to 1 of 2 first-stage FI interventions: 1) an electronic health record (EHR)-based WIC
referral or 2) EHR WIC referral + care navigation. Participants who do not have an improvement in FI will be
re-randomized to 1 of 2 second-stage interventions: 1) produce vouchers or 2) medically-tailored meals.
In Aim 1, we will determine the feasibility of recruitment and which first-stage intervention is potentially more
effective in reducing FI. In Aim 2, we will evaluate the feasibility of re-randomization, data collection, and
retention and assess which FI intervention may be the best next step for those who do not respond to the initial
intervention. In Aim 3, we will explore heterogeneity in response to the first and second stage interventions by
conducting semi-structured interviews with participants.
The proposal complements NIDDK’s priority to “understand the impact of metabolic dysfunction on the
intrauterine environment and subsequent metabolic health of mother and offspring.” This study is the first to
evaluate an adaptive FI intervention in pregnant patients. Given health systems’ focus of integrating FI
interventions in clinical practice, an efficacious adaptive intervention could be broadly disseminated. Adaptive
interventions can reduce the burden and costs for patients and providers by providing no more treatment than
is needed for patients who respond to a less intensive approach and redirecting the saved resources to those
who need a more intensive approach. Our team of established investigators has successfully used the
methods proposed and has the full support of the health system where the study will occur.

Public health relevance
Project Narrative Food insecurity affects up to 30% of pregnancies, disproportionally impacts racial and ethnic minorities, and leads to worse health in pregnant people and their children, including an increased risk of gestational diabetes, pre-term birth, and future cardiometabolic chronic conditions (e.g., type 2 diabetes and obesity). Interventions are being utilized to address food insecurity in clinical care settings, but patients differ in the support they need to reduce food insecurity and health systems have limited resources to invest in these interventions. Rather than a single intervention, adaptively allocating interventions could be a more effective, equitable, and efficient approach to improve food security; the objectives of this pilot study are to determine the feasibility of recruiting, retaining, and adaptively providing food insecurity interventions to pregnant patients in anticipation of a large, definitive trial in the future.